Uncovering and understanding the many functions of ICAM-1 in the lungs during homeostasis and innate immune responses

Abstract
The gene Icam1 codes for intercellular adhesion molecule-1 (ICAM-1, CD54), a member of the Ig-like superfamily
of adhesion proteins and a type 1 membrane-bound glycoprotein. It is expressed constitutively on most lung
parenchymal cells, functioning as a receptor for interactions between these parenchymal cells and leukocytes.
Its major ligands are the four members of the β2 leukocyte integrin family. Our laboratory has contributed to
understanding both the adhesive and the signaling functions of ICAM-1. We identified the differential expression
of ICAM-1 on AT1 compared to AT2 cells and its upregulation by lipopolysaccharide and S. pneumoniae on
these cells and capillary endothelial cells. During inflammatory responses, cytokines such as IL-1, TNF and IFNγ
regulate its expression differentially, depending on both the cell type and the inflammatory stimulus. Our studies
of its cell-cell adhesive function document its critical roles in pneumonia induced by LPS and P. aeruginosa.
Ligation of ICAM-1 by β2 integrins also induces intracellular signaling within both the parenchymal cell and the
leukocyte. Furthermore, ICAM-1 is proteolytically shed from the surface of parenchymal cells, and this soluble
ICAM1 (sICAM-1) has highly debated functions as an inhibitor of leukocyte adhesion or an activator of
leukocytes. Thus, ICAM-1 plays very dynamic roles during inflammatory and immune responses. Due to recently
identified issues with the Icam1 null mice generated by homologous recombination and the lack of cell-specific
knockouts, we are at a standstill in understanding ICAM-1. We are generating both Icam1 null mice using
CRISPR/Cas9 and mice with floxed Icam1 alleles. We will test the hypothesis that membrane-bound and sICAM-
1 mediate a range of cell-cell interactions that depend upon the particular ICAM-1-expressing cell type during
both homeostasis and innate immune responses. Aim 1 determines the functions of sICAM-1 in the alveolar
space and its therapeutic potential. The role of sICAM-1 in the trafficking of alveolar macrophages along the
alveolar surface and the functions of sICAM-1 in recruitment and function of neutrophils and inflammatory
macrophages during pneumonia will be identified. Aim 2 determines the functions of ICAM-1 on the alveolar
surface during homeostasis and innate immune responses. Mice deficient in ICAM-1 in alveolar epithelial cells
will be studied to determine its role in trafficking, motility and function of alveolar macrophages in healthy mice.
The effect of alveolar epithelial ICAM-1 in recruitment and function of neutrophils, macrophage subpopulations
and NK cells during pneumonia will also be determined. Outside-in signaling initiated by ICAM-1 ligation will also
be assessed. Aim 3 determines the functions of endothelial ICAM-1 during innate immune responses. Mice
deficient in ICAM-1 expression by endothelial cells will be studied to determine if the leukocytosis observed in
Icam1 null mice is due to the absence of endothelial ICAM-1, as well as the functions of endothelial ICAM-1 in
neutrophil, macrophage and NK cell trafficking during pneumonia. Signaling pathways will be assessed. These
studies will expand our knowledge of ICAM-1 and its therapeutic potential.

Public health relevance
ICAM-1 is an adhesion molecule expressed on the surface of alveolar epithelial cells, endothelial cells, immune cells, and other parenchymal cells that mediates parenchymal cell-leukocyte adhesion and outside-in intracellular signaling through binding to β2 leukocyte integrins during homeostasis and the innate immune response. Studies of ICAM-1 are stymied by the critical need for mice generated by CRISPR/Cas9 technology and for cell-specific Icam1 knockout mice. We are generating mice deficient in ICAM-1 in alveolar epithelial cells or endothelial cells and propose to study the function of both membrane-bound and soluble ICAM-1 in clearance of alveolar surfaces by alveolar macrophages, maintenance of circulating neutrophil counts, sequestration of neutrophils by intravascular inflammatory mediators, and inflammatory and innate immune responses to S. pneumoniae and P. aeruginosa, two common and clinically relevant bacteria that recruit neutrophils through different adhesion pathways, so that we can understand this interesting and critically molecule and assess its potential as a therapeutic target.